Using Biomedical Knowledge to Identify Plausible Signals for Pharmacovigilance

DESCRIPTION (provided by applicant): The need to monitor unintended effects of approved drugs has been highlighted by several recent high-profile events in which fatal side effects of drugs were detected after their release to market. Notoriously, the Cox-2 inhibitor Rofecoxib (Vioxx) was withdrawn from market on account of evidence suggesting that treatment with the drug increased the rate of coronary artery disease, and recently new evidence has emerged suggesting the commonly used antibiotic Azithromycin (Zithromax) may cause fatal arrythmias. In an effort to mitigate the morbidity and mortality resulting from such undetected side effects, regulatory bodies such as the Food and Drug Administration (FDA) have instituted spontaneous reporting systems to systematize post-marketing surveillance. However there is evidence that under-reporting of adverse drug events (ADEs) is widespread. Automated monitoring of events documented in the Electronic Health Record (EHR) as free text or structured data has been proposed as a path toward earlier identification of meaningfully correlated drug-event pairs. As these pairs must ultimately be reviewed by domain experts to assess their implications, there is a pressing need to develop methods to selectively identify plausible drug-event pairs within the large pool of correlations to be found in clinical data. In the proposed research, we will develop and evaluate models of biological plausibility, based on knowledge extracted from the biomedical literature and using methods of hyperdimensional computing for efficient search and inference across multiple concepts and relations simultaneously. These methods will be used to selectively identify plausible drug-event pairs found in structured clinical data, and extracted from unstructured data using natural language extraction. The developed methods will be evaluated formatively, for their ability to rediscover known side effects from the biomedical literature, and summatively for their ability to improve the precision of effects attributed to a st of known drugs using statistical methods alone. In addition we will evaluate their ability to predict recent FDA warnings, using historical data and knowledge. If successful, the proposed research will provide the means to identify automatically plausible drug-event pairs for regulatory purposes, mitigating consequent morbidity and mortality. In addition, the methods will provide a generalizable approach that can be used to apply knowledge derived from the biomedical literature to interpret clinical data.

Public health relevance
Project Narrative The need to monitor unintended effects of medications has been highlighted by several high-profile events in which fatal side effects of approved drugs were detected after their release to market. In the proposed research, we will develop and evaluate methods to identify automatically biologically plausible adverse drug events found within clinical patient records, using knowledge extracted from the biomedical literature. If successful, these methods will provide the means for earlier detection of harmful drug effects, limiting consequent morbidity and mortality. __SpecificAimsTextDelimiter__ A. Specific Aims (1 page) The need to monitor unintended effects of approved drugs has been highlighted by several high-profile events in which fatal side effects of approved drugs were detected after their release to market. Regulatory bodies such as the Food and Drug Administration (FDA) have instituted Spontaneous Reporting Systems (SRS) in an effort to systematize post-marketing surveillance. However, there is evidence of widespread under-reporting of adverse drug events (ADEs), including those with severe consequences (1). Leveraging data resources such as Electronic Health Records (EHRs) may improve ADE detection (2), and recent research has demonstrated the feasibility of Natural Language Processing (NLP) as a means to extract meaningful diseases-event co- occurrence statistics from the EHR for this purpose (3). However, these methods retrieve large numbers of associations, only some of which are "real." Thus, automatically-identified associations must be manually reviewed by domain experts (4). As the availability of the prerequisite expertise is limited, there is a pressing need to distinguish plausibly-causal relationships from the large number of false positive associations that may occur by chance. We hypothesize that this can be achieved by integrating knowledge-driven estimates of plausibility into the pharmacovigilance process. We propose to develop and evaluate an approach toward inferring the biological plausibility of drug-ADE associations, using large quantities of knowledge extracted from the biomedical literature, with the following Specific Aims (SAs): SA1 : Identify associations in EHR data (signal detection) SA1.1 : Extract drug and potential ADE entities using NLP SA1.2 : Use statistical methods to identify strongly correlated drug-event associations We will use publicly available NLP tools, and novel enhancements of currently available methodologies, to extract drugs and potential ADE mentions in the EHR. We will then utilize established statistical methods to estimate the significance of drug-ADE associations. Methods of concept extraction will be evaluated for accuracy, to ensure the detected signal is of adequate quality. In addition, statistical methods that have been used for pharmacovigilance in the past will be evaluated for their ability to detect known side effects. SA2: Develop and evaluate models of plausibility SA2.1 : Infer models of plausibility from known drug-ADE pairs SA2.2 : Evaluate whether these models can "discover" other known side-effects We will develop and evaluate scalable models of biological plausibility using an existing set of over 50 million subject-predicate-object triples extracted from the biomedical literature by the SemRep system (5). We will use methods for efficient inference of pathways of predicates (6), such as "drug X STIMULATES substance Y CAUSES side-effect Z", from known examples. These pathways will be evaluated for their ability to rediscover a held-out set of known drug-ADE relations and manually reviewed by domain experts. SA3: Evaluate the effects of the plausibility models on ADE detection SA3.1 : Construct a test set SA3.2 : Evaluate effects of models from SA2 on precision of EHR-derived ADEs SA3.3 : Evaluate ability of developed methods to predict newly added label warnings We will derive a test set of drugs and well-established side effects using two publicly available databases: SIDER (7), a database of drug side-effect relationships derived from public documents and package inserts, and the FDA's adverse event reporting system database, which contains reports of adverse events observed in practice. We will evaluate the effect of our plausibility models (SA2) on the precision of suggested side effects derived from the EHR (SA1), to determine the extent to which our models of plausibility can enhance the precision of retrieved results. In addition, as a summative evaluation, we will evaluate the ability of our methods to predict the addition of new side effects to the labels of existing drugs, using only data that were available prior to the addition of the warning to the package insert. At the conclusion of this project, we will have developed and evaluated methods to "filter" the output of traditional methods, which suffer from low precision (i.e., they retrieve many false associations; high false positive rate). If we are even partly successful, we will reduce the work required of human experts who review potential associations. To this end, we have assembled a team of experts in biomedical informatics, pharmacology, biostatistics, clinical health care, NLP and computational linguistics. We already have access to the necessary infrastructure including NLP tools (both licensed and publicly available), servers within a secure environment with policies and procedures for computing on EHR data, as well as the necessary clinical data assembled over years. Thus, we are uniquely positioned to undertake the proposed work.